A mechanistic neuroimaging study to determine brain changes with auricular stimulation and auriculotherapy in healthy volunteers and chronic low back pain patients

Project Summary - Abstract
There is a critical unmet need for effective low-cost, non-invasive, opioid-sparing treatments for chronic pain,
particularly chronic low-back pain (CLBP). Auriculotherapy (AT) is a promising alternative treatment for chronic
pain that is underutilized, in large part due to lack of demonstration of systems-neuroscience changes that
provide a mechanistic explanation for the beneficial clinical effects. Our overall objective in this proposal is to
determine the neural signatures of experimental stimulation (stim) and durable modulation of brain network
connectivity following AT treatment, using multi-modal neuroimaging. Aim 1 involves a basic experimental study
in pain-free volunteers that will evaluate, using functional near-infrared spectroscopy (fNIRS), whether nontherapeutic touch stim with von-Frey filaments applied to different ear points will cause distinct activations in the
primary somatosensory cortex and prefrontal cortex, testing assumptions about the accepted auricular
cartography used for AT practice. Aims 2 and 3 involve a 1:1 randomized double-blind sham-controlled
mechanistic clinical trial in CLBP patients, who will return after a 2-month washout period for crossover condition.
The filament stim fNIRS paradigm described for Aim 1 and whole-brain resting-state functional MRI will be
performed both before and 5-7 days after verum/sham AT. For AT, we will use compressed gas (Cryo-AT) to
provide focal, needle-free, persistent stim of AT points. Cryo-AT is barely perceptible, allowing patient blinding
and rigorous sham control by using a device with an empty canister at the same AT points. Cryo-AT has been
shown to be as effective and well-tolerated as needles, and we have previously demonstrated long-lasting
effectiveness for cryo-AT. In Aim 2 fNIRS stim data will be used to test the hypothesis that low-back AT points
are sensitized or pathologically imbalanced in CLBP. Stim of the low-back AT point is expected to elicit a greater
magnitude fNIRS response compared to the pain-free cohort of Aim 1 and compared to stim of AT points
representing pain-free body areas in CLBP patients. When repeating the fNIRS stim paradigm 5-7 days later,
significantly smaller fNIRS responses from low-back AT points are expected when patients receive Cryo-AT
treatment compared to sham, demonstrating resolution of the pathologic imbalance. In Aim 3 fMRI data will be
analyzed for long-lasting changes in network connectivity. We expect significantly greater connectivity change
following Cryo-AT treatment, as the primary outcome. In a secondary analysis, changes in pain, anxiety, and
depression will be regressed against the connectivity-change contrast for individual anatomical regions of
interest, to localize changes in pain and mood to specific brain areas with connectivity changes after Cryo-AT.
Overall Impact: Our world-class multidisciplinary team, with expertise in AT, fNIRS, MRI, and clinical pain
research, from an excellent environment, will expeditiously complete this study and provide mechanistic
neuroscientific insights into the beneficial effects of AT. This will increase the adoption of AT in routine clinical
care to improve pain relief and mood, while avoiding excess opioid use in millions of Americans with CLBP.

Public health relevance
Public health relevance statement = Project Narrative Chronic low-back pain affects millions of Americans and is associated with expensive surgery, excessive opioid use, poor mental health, and lost productivity. Auriculotherapy is an opioid-alternative and cost-effective non- invasive treatment modality that reduces pain and improves mood by external ear stimulation, but its adoption into mainstream clinical practice is hampered by lack of a mechanistic understanding of its beneficial effects on the human brain. This proposal will fill this gap in knowledge using multimodal brain imaging in studies of chronic low-back pain patients and healthy controls, demonstrating both the immediate brain responses to ear stimulation and longer-term changes in brain networks following auriculotherapy treatment.